Capacity for antibiotic susceptibility testing and bacterial sequencing at Cornell AHDC

Project Summary/Abstract There is a growing need for monitoring antimicrobial resistance in animals in order to protect the safety of people and animals. Improving capacity for isolate banking, accredited antibiotic susceptibility testing, and bacterial whole genome sequencing in veterinary diagnostic labs thus supports the mission of FDA to ensure the safety of our nation's food supply and protect public health. In this proposal, we request critical equipment needed to strengthen capacity in the Cornell Animal Health Diagnostic Center. The capacity to perform advanced molecular characterization of bacterial isolates in a reliable manner is critical to our ability to respond quickly to suspected microbiological contamination and monitor antimicrobial resistance in animals and feed. The proposed studies will have important impacts for both human and veterinary health and will improve the capabilities of the Vet-LIRN to perform effective surveillance for food-borne pathogens.

Public health relevance
Project Narrative There is a growing need for accredited testing for antimicrobial resistance in veterinary diagnostic labs to support the mission of FDA to protect public health. We propose to purchase automation and freezer equipment to improve our capacity to provide these services and bank bacterial isolates from animals. We will support other network labs by providing Quality Assurance documentation in support of ISO:17025 accreditation and development of harmonized procedures.